BEAT-HIV: Delaney Collaboratory to Cure HIV-1 Infection by Combination Immunotherapy

Project Summary The absence of a cure for HIV-­1 after antiretroviral therapy imparts multiple burdens to the infected individual (stigma, criminalization, life-­long therapy), US society (continued infections, internal health care costs, PEPFAR), industry (pricing versus access, capacity for world-­wide drug production), and global resource governance (UNAIDS, AIDS orphans, Global Fund, effects of declining economy on country/region HIV therapy programs, etc.) justifying a focused investment in identifying novel strategies to achieve a cure and/or stable remission after HIV infection. The BEAT-­HIV Delaney Collaboratory to cure HIV-­1 infection by combination immunotherapy has three central objectives. First, identify the best approach to target immunotherapy against replication competent reservoirs by defining the relationship between plasma and tissue clonal expansion, characterize integration sites within blood and tissue, and determine how to maximize viral reactivation of distinct reservoir compartments. Second, test clinical strategy combining IFN-­α immunotherapy to activate intrinsic/innate responses and ADCC with broadly neutralizing anti-­HIV antibodies (both strategies shown to have an effect in humans when used singly);? advance preclinical studies on IFN-­ alpha response, ex vivo combinations with added T-­cell-­mediated strategies, and develop innovative DNA vaccine delivery systems for sustaining neutralizing antibodies in vivo. Third, test clinical strategy that combines two gene therapy vectors to intrinsically protect HIV-­specific killer cells by a ?CCR5 zinc nuclease given together with a CAR delivering HIV-­specificity to CD8 T-­cells;? advance the preclinical humanized mice platform to test novel combinations of immunotherapy (with/without novel delivery) when administered jointly or in sequence with the objective to recruit maximal intrinsic, innate, and/or adaptive anti-­HIV effects. Objectives are supported by four support teams addressing Clinical, HIV reservoir measures, HIV evasion analysis, and Biostatistics and Data Management. Community engagement takes advantage of a 20+year relationship with the local HIV community, CFAR, and ACTG activity ensuring partnership with target populations. Central administration of resources will ensure maintenance of high impact milestones, study team communications, and yearly goal-­oriented resource allocation and/or redistribution as informed by an executive committee, external advisory board, and NIH program. As a group, we bring diverse expertise and innovation representing the first time that distinct immunotherapy strategies with initial promising results in human trials focused on intrinsic/innate, humoral and adaptive arms of the immune response are actively joined to advance an HIV cure and/or remission under a single common multi-­investigator, multi-­industry team. The entire team is committed to advance the best outcomes from our collective effort to ultimately develop a strategy to eradicate HIV.

Public health relevance
Project Narrative The inability of antiretroviral therapy (ART) to clear HIV infection, and the observation that a sterilizing cure and/or stable remission can be achieved by a subset ART- treated persons has galvanized the interest to advance clinical strategies towards a cure and/or stable remission. Here we will build on clinical preliminary data from several single agent immunotherapy human trials that indicate a potential to inhibit HIV beyond ART. Including scientists from 8 Institutions and 4 Industry partners, the BEAT- HIV Delaney Collaboratory will seek to develop and test innovative combined immunotherapy strategies to eradicate and/or permanently suppress HIV into remission in the absence of ART.